Imaging, Guidance, and QA for Emerging High-Precision Neurosurgical Techniques

PROJECT SUMMARY / ABSTRACT
Emerging neurosurgical techniques offer potential breakthroughs in treatment of a growing spectrum of movement
disorders and dementia (including Alzheimer’s disease, Tourette’s syndrome, autism, depression, and even obesity). These
emerging surgical approaches extend the established success of deep-brain stimulation (DBS) in Parkinson’s disease by
using novel electrode stimulators delivered trans-ventricularly to targets about the hypothalamus. While endoscopic
approach provides reliable access to the ventricles, such access imparts a loss of cerebrospinal fluid (CSF) and brain shift
up to ~10 mm in the very regions of interest for these novel DBS therapies. Therefore, realizing the benefit of such
promising techniques requires advances beyond the state of the art in neuro-navigation. Moreover, the use of novel,
directional electrodes in such techniques requires a means to guide and confirm stimulator placement. Especially in the
early stages of development of such novel therapies, it is important to resolve uncertainties related to geometric precision
in order to differentiate from underlying neurophysiology and other factors that may affect safety and outcome.
We propose to develop and evaluate the following advances in intraoperative imaging, registration, and guidance to
realize a platform for robot-assisted ventriculoscopic approach to deep-brain targets in a manner that overcomes
conventional limitations of neuro-navigation and supports the emerging generation of novel DBS therapies:
(Aim 1) Develop high-quality intraoperative cone-beam CT (CBCT) using 3D image reconstruction methods that propel
image quality beyond conventional limits of CBCT, providing image quality sufficient to drive deformable registration with
preop MRI, precisely localize stimulator placement, and provide a check against complication / intracranial hemorrhage.
(Aim 2) Develop 3D-2D image registration methods to relate low-dose intraoperative radiographs with: (a) preop MRI for
automatic patient registration; and (b) parametric models of DBS electrodes (including novel directional stimulators) for
guidance and confirmation of stimulator placement with precision and accuracy beyond that of conventional tracking.
(Aim 3) Develop multi-modality deformable image registration (MR-CBCT) to resolve alignment between preop MRI and
intraoperative CBCT – particularly peri-ventricular deep-brain deformation following CSF egress – using a fast, modality-
insensitive, diffeomorphic Demons method for accurate transformation of MRI / planning data to CBCT and endoscopy.
(Aim 4) Develop endoscopic video registration to render 3D image and planning information directly in the endoscopic
scene, providing accurate visualization of target and critical structures during ventriculoscopic approach.
(Aim 5) Translate the methods from Aims 1-4 to clinical studies for quantitative evaluation of performance under realistic
conditions, and combine within an integrated system for robot-assisted ventriculoscopy (RAV) approach to DBS targets.
The proposal advances previous work in skull base and spinal neurosurgery, offering a high likelihood of success in enabling
next-generation DBS, and creates an integrated system for image-guided surgical robotics beyond the state of the art –
a valuable testbed for development and translation of clinical systems under future academic-industry partnership.

Public health relevance
PROJECT NARRATIVE Emerging neurosurgical techniques seek to deliver novel deep-brain stimulators for treatment of a spectrum of neurological movement disorders and dementia, and endoscopic approach offers optimal access to targets. Conventional neuro-navigation suffers unresolved geometric error (up to 10 mm) from deep-brain deformation, and the current state of the art therefore does not meet the high degree of targeting accuracy required in these emerging techniques. This research advances imaging and registration methods to resolve deformation, provide accurate guidance, render targets directly in endoscopic video (even beyond the visible surface of the ventricle), verify stimulator placement, and give a check on complications (with opportunity to revise if necessary). Individual advances are translated for the first time to clinical studies and combined in an integrated prototype for image- guided, robot-assisted, trans-ventricular delivery of next-generation deep-brain stimulation (DBS).